Mechanisms of SEMA4D mediated breast cancer to brain metastasis

Summary
Brain metastasis accounts for significant morbidity and mortality of many cancer types, the two most common
being lung and breast cancers. This devastating complication is initiated by a rare subset of the circulating
tumor cells (CTCs) shed into the blood stream. The crossing of the blood-­brain barrier (BBB) by CTCs is the
first critical step that initiates brain metastasis. Thus, understanding how CTCs can breach the BBB is critical
for developing means to predict, prevent, or treat brain metastasis. Our recent study using ex vivo expanded
CTCs isolated from breast cancer patients identified a transmembrane surface receptor, SEMA4D, promotes
brain metastasis by enabling CTCs to cross the BBB via binding to its ligand PLXNB1 on the brain endothelial
cells (BECs). Our preliminary data now show that SEMA4D stimulation leads to YAP/TAZ signaling in tumor
cells, a pathway well known to promote cell motility and migration, and recently implicated in the development
of brain metastasis. Therefore, we hypothesize a role for “reverse signaling” through the SEMA4D
cytoplasmic tails to activate YAP signaling for synergizing with SEMA4D-­PLXNB1 tethering to the BECs to
breach the BBB. We will utilize our unique resources of patient-­derived CTCs, and in vitro and in vivo BBB
transmigration assays to test our hypothesis. The overall objective of this proposal is to dissect the detailed
mechanisms linking SEMA4D to YAP signaling, and the role for YAP in SEMA4D-­mediated BBB transmigration.
Delineating the combinatory effect of SEMA4D and YAP signaling will allow us to design potential therapeutic
approaches to prevent SEMA4D-­mediated brain metastasis. Such knowledge will also provide a mechanistic
basis for identifying additional BBB transmigration initiators that could act similarly through receptor tethering to
BECs and subsequent activation of YAP, which could have a broader impact on identifying predictive
biomarkers for brain metastasis.

Public health relevance
Project Narrative A devastating complication of many cancers, brain metastasis is initiated by a subset of circulating tumor cells (CTCs) shed into systemic circulation. This proposal aims to dissect the mechanisms of a transmembrane receptor in mediating the CTCs to cross the blood brain barrier, the first critical step for establishing brain metastasis. This proposed research could significantly advance our understanding of the molecular drivers for the first step of brain metastasis and facilitate the development of predictive markers and targeted therapies for brain metastasis.